The Role of Lysyl Oxidase in Epithelial Differentiation in Eosinophilic Esophagitis

PROJECT SUMMARY This R03 proposal stems directly from studies and career development activities outlined in Dr. Muir’s K08. This award represents a new research direction that will enhance Dr. Muir’s advancement towards independence. This award will allow Dr. Muir to obtain additional skills in combining genetically altered cells with three-dimensional culture systems in order to define novel mechanisms of esophageal epithelial differentiation with direct relevance to eosinophilic esophagitis (EoE). This will be achieved with the guidance of research mentors, Drs. Rustgi and Nakagawa and my K08 interdisciplinary advisory committee of Drs. Herlyn (Chair), Tong, and Heuckeroth. Eosinophilic esophagitis (EoE) is an allergic disease characterized by esophageal infiltration of eosinophils. In addition to inflammatory cell invasion, this disease is characterized histologically by epithelial changes, specifically failure of epithelial differentiation leading to basal cell hyperplasia. Under homeostatic conditions, esophageal epithelial differentiation is known to be regulated by the Notch family of receptors, however, little is known about Notch regulation in the context of EoE. Through the work of the ongoing K08, Dr. Muir has investigated the role of collagen cross linking enzyme, lysyl oxidase (LOX) in promoting fibrosis in EoE. In the work presented in this proposal, she now seeks to determine the effects of this enzyme on esophageal epithelial differentiation. Dr. Muir’s preliminary data demonstrate that LOX affects the epithelial proliferation- differentiation gradient in the esophagus. In LOX over-expressing esophageal epithelial cells (EPC-LOX) there is loss of epithelial differentiation in 3D organoid culture and Notch signaling is suppressed. Based on these findings the overall hypothesis is that LOX-mediated suppression of Notch signaling contributes to EoE pathobiology by limiting squamous differentiation and promoting barrier defects. Guided by strong preliminary data, this hypothesis will be tested by pursuing two specific aims: 1) Determine the relationship between LOX and EoE-associated impairment of epithelial differentiation and integrity and 2) Determine the how LOX-mediated modulation of Notch signaling influences squamous differentiation. Under the first aim, she will evaluate the effects of LOX overexpression on proliferation-differentiation and barrier integrity utilizing functional assays of cell proliferation and barrier integrity. In the second aim, she will define how Notch signaling contributes to impaired squamous differentiation in the context of LOX over-expression. The approach in this proposal is innovative because it utilizes a novel esophageal 3D organoid culture system which recapitulates esophageal histology and epithelial differentiation observed in vivo. The proposed research is significant as it seeks to elucidate the role of LOX in esophageal epithelial differentiation and provide the basis for future studies with translational applications in the management of EoE.

Public health relevance
PROJECT NARRATIVE Eosinophilic esophagitis (EoE) is a chronic allergic disease characterized by altered epithelial differentiation and loss of barrier integrity. This proposal seeks to elucidate the role of epithelial derived lysyl oxidase (LOX) in disrupting esophageal epithelial proliferation and differentiation. Results from this study will lead to a more precise understanding of the mechanisms of esophageal epithelial differentiation allowing for the development of new therapeutic strategies to restore epithelial homeostasis.